Executive Functioning and Physical Activity in Adolescents At-Risk for Type 2 Diabetes

Project Abstract/Summary
Prevention of youth-onset type 2 diabetes (T2D) is critical. Rates are escalating, especially in adolescent girls of
color, and youth-onset T2D is difficult to treat and presents with a more aggressive course than adult-onset.
Efficacious T2D prevention requires a more rigorous understanding of the underlying mechanisms of action that
facilitate behavior change. Although physical activity is protective against worsening insulin resistance, a key
antecedent of T2D, exercise training shows insufficient effectiveness for producing sustained change in physical
activity, weight, or metabolic health in adolescents with obesity. The overarching hypothesis of the parent study,
R01DK111604-01, is that depression is a driver of the difficulties that many adolescent girls at risk for T2D
experience in initiating/sustaining physical activity. In the parent RCT, we are testing the hypothesis that
delivering an empirically-supported depression intervention, cognitive-behavioral therapy (CBT), to decrease
depression, followed sequentially by exercise training, will offer an efficacious strategy for increasing physical
activity and improving insulin resistance. In this administrative supplement (NOT-OD-22-140), our overarching
goal is to illuminate executive functioning (EF) dimensions that underlie decreasing depression and increasing
physical activity. EF is theoretically central to self-regulation of cognitions/behaviors that support physical activity
initiation and maintenance. Yet, in adolescents with obesity, most data are associational, directionality is unclear,
and specific EF dimensions relevant to physical activity are not entirely understood. Elucidating dynamic, time-
ordered changes that unfold in depression, EF, and physical activity throughout 12-week CBT/exercise could
facilitate future intervention tailoring/optimization for adolescents at risk for T2D with mood concerns. However,
rigorous tests of mechanisms of action require intensive repeated measures to capture temporal ordering during
the intervention phase, making it essential to first establish feasibility/acceptability of intervention-phase
intensive, repeated measures. Leveraging the parent RCT, we propose a feasibility and proof-of-concept study
of EF as mechanism of action in N=95 (sample subset) adolescent girls at risk for T2D with elevated depression.
Specific aims of this 1-year supplement are to: (1) Test feasibility/acceptability of intensive repeated measures
of depression, EF, and physical activity across four 12-week (6-week6-week) sequences in girls at risk for
T2D: i) CBTexercise, ii) exerciseCBT, iii) CBTCBT, and iv) exerciseexercise; (2) Describe longitudinal/
time-ordered changes and change-to-change associations for depression, EF, and physical activity across the
intervention; and (3) Explore group differences in longitudinal/time-ordered change-to-change associations. This
supplement fosters new collaborations with experts in neurocognitive processes in health behavior
(Goldschmidt) and advanced statistics for longitudinal, intensive repeated measures (Aichele). Establishing
feasibility/acceptability and proof-of-concept of EF's role in physical activity would lay a foundation for future tests
of EF as a mechanism of action to be tested, and/or enhanced as a target, in future CBT/exercise interventions.

Public health relevance
Project Narrative The proposed research is highly relevant to public health because understanding cognitive and behavioral processes that underlie health behavior change, such as physical activity, among adolescents with obesity and depression offers the prospect of mitigating type 2 (T2D) diabetes risk. Regular physical activity is protective against worsening insulin resistance, a key precursor of T2D; however, initiating and maintaining regular physical activity among adolescent females with obesity and depression may be negatively impacted by deficits in executive functioning, a set of neurocognitive processes that facilitate goal-directed health behavior. By rigorously examining depression, executive functioning, and physical activity via repeated assessments during the treatment phase of a currently funded project testing cognitive-behavioral therapy and exercise training for adolescent females at-risk for T2D with elevated depression symptoms, the proposed study has the potential to illuminate how and why T2D prevention may reduce risk in vulnerable adolescents.